Performance evaluation of a non-invasive menstrual test for endometriosis in infertility patients

Summary
Endometriosis is a complex disease that on average, involves a ten-year gap between symptom onset and
diagnosis, with profound consequences on fertility outcomes. Moreover, due to the current surgical nature of
endometriosis diagnosis (laparoscopy), research studies involving confirmed cases are both difficult to obtain
and costly to recruit for. Laparoscopic surgery (recovery times 2-6 weeks) followed by histological confirmation
is considered the gold standard for diagnosis. However, even with surgical intervention, 50% of patients have
recurrence, underlining the fact that endometriosis shows periodic states of activation, regardless of surgical or
therapeutic intervention. Consequently, a non-invasive, reliable biomarker test for endometriosis is a significant
unmet medical need.
A non-invasive diagnostic for endometriosis would motivate earlier detection of disease and could fundamentally
change a patient’s prognosis by preventing disease progression. Menstrual fluid is a rich source of reproductive
tissue that can be utilized for disease diagnosis. NextGen Jane has developed a menstrual effluence collection
system, which addresses issues of non-invasive sample accessibility and ease of sample transport to a
laboratory.
Toward commercialization of a reliable test to aid in the diagnosis of endometriosis among patients with infertility,
our preliminary data has produced a high-performance genomic assay for the detection of endometriosis. We
have performed initial testing of this assay on an independent dataset of 65 participants (38 cases and 27
controls) with high performance (an area under the curve AUC of 0.89). These factors alongside the
demonstrated utility of our collection system differentiates this proposal from other non-invasive approaches to
detection of endometriosis.
Our goal is to commercialize this non-invasive” yes/no” diagnostic tool by performing the validation studies within
the intended-use population of subfecund patients, as well as evaluate how well the assay performs when
adenomyosis and fibroids are also present, which represents other leading causes of infertility.

Public health relevance
The goal of this SBIR Direct to Phase II is to perform validation studies toward the commercialization of a non-invasive molecular assay to aid in the diagnosis of endometriosis when infertility is present. The development and validation of this assay are based on data produced during our Phase I and Phase II FastTrack SBIR ("Developing a non-invasive, definitive diagnostic for endometriosis using biomarkers in menstrual effluence." – 5R44HD103159)